INHALED NITRIC OXIDE TO REDUCE HYPOXEMIA AND MORBIDITY OF INFANTS

To examine whether low levels of nitric oxide inhaled by infants with persistent pulmonary hypertension can reverse hypoxemia, thus reducing morbidity and mortality.